Access for All in ALS (ALL ALS) West Clinical Coordinating Center

Abstract
Amyotrophic lateral sclerosis (ALS) is a rapidly progressive, ultimately fatal, neurodegenerative
disease with approximately 32,000 cases in the United States (US). With an estimated lifetime
risk of 1/400, an average of 5,000 new US cases are diagnosed every year. A public private
partnership (PPP) can be leveraged to rapidly advance regulatory science and scientific research
to support and accelerate the development of effective, new drugs to extend life for people living
with ALS. Given the numerous failures in translating laboratory results into clinically effective
therapies, the generation of high quality, diverse and longitudinal patient-derived biosamples and
resulting downstream data is critical for our success. To this aim, our proposed ALS Clinical
Research Coordinating Center (ALSynCC) builds and expands upon the ongoing success of our
Target ALS Natural History study and consortium and will include five sample/data repositories
linked to detailed clinical information: 1) a biofluid repository that contains cross-sectional and
longitudinal biofluid sample from asymptomatic and symptomatic patients where samples are
linked to detailed clinical information, whole genome sequencing, at-home measures of speech
and respiratory function, 2) a longitudinal study of asymptomatic mutation carriers called the
PREVENT study that will be expanded to include participants across the country, 3) an MRI-
based neuroimaging repository to be newly implemented, 4) at-home measures of speech and
respiratory function, and 5) a large, well-annotated post-mortem tissue biobank containing brain,
spinal cord and muscle tissue from patients. Each of these repositories is led by highly trained
physicians and scientists, experts in the field. This use of multi-modal and multi-compartment
sampling from each patient is a powerful method to characterize disease processes and will
improve translation of diagnostics, therapies, and outcome measures to the clinic. These highly
curated biosamples and data resources are de-identified, linked to detailed clinical information,
and will be made immediately available to the research community through the Consortium data
portal. Our Target ALS natural history program is a successful public-private partnership between
academic and industry leaders and closely mirrors the overall goals of the proposed ALS Clinical
Research Consortium and functions of the Coordinating Center (CC). A unique aspect of our
model is to collect data and samples from asymptomatic individuals at risk for ALS, as well as
from symptom onset to autopsy to provide a comprehensive sample and dataset for future
research studies. We will utilize our knowledge and tremendous success to expand on this
existing infrastructure to maximize ALS patient enrollment in a highly synchronized research
platform called ALSync that is administered by the ALSynCC. This nationwide ALSync network
will work closely with NIH and other partners to coordinate and bridge ALS research and clinical
care across the country to: a) ensure inclusion of male and female patients of all racial and ethnic
backgrounds, b) to improve access to clinical research and trials, c) to generate high quality
patient samples and data, and d) to efficiently share data and analysis tools to accelerate research
in the broader ALS community.